CONSOLIDATED FACILITIES REQUIREMENTS FOR FY22 TASK ORDER-A.

PURPOSE OF THE PROJECT / TASK
1.1 This project is intended to upgrade the existing fire alarm systems in 30+
Frederick National Laboratory Buildings at Ft. Detrick.
2.0 PROGRAM OF REQUIREMENTS
2.1 General Requirements
2.1.1 Required Site Interfaces. This will be a subcontracted construction
project performed throughout Ft. Detrick.
2.1.2 Parking. There is minimal parking in the area for the craft workers. A
Parking / Laydown Area will be determined and presented to the
Contractor as part of the procurement process.